Administrative Core

PROJECT SUMMARY - ADMINISTRATIVE CORE (CORE A)
The overall mission of the Wisconsin Alzheimer's Disease Research Center (ADRC) is to provide an
infrastructure and resources conducive to conducting cutting-edge extramurally funded research in Alzheimer's
disease (AD) and related disorders, with a special focus on preclinical biomarkers of AD and their role in
predicting transition from preclinical to clinical stages of the disease. The Administrative Core will set overall
research directions and priorities, oversee all Core-related activities, ensure optimal utilization of the ADRC
resources, and serve as a resource to expand AD and aging research locally, nationally, and beyond.
Under the overall scientific and administrative leadership of Sanjay Asthana, MD, the Wisconsin ADRC Director,
the Administrative Core will continue to exercise its leadership and accomplish its objectives through the activities
of four major committees. The External Advisory Committee, comprised of distinguished leaders in AD research
at institutions outside of Wisconsin and with expertise aligned with the scientific missions of the ADRC, provides
advice concerning the overall direction and performance of the Center. The Executive Committee, comprised of
the ADRC Director, Associate Director, Administrator, Core Leaders, Core Co-Leaders, and Data Leader, meets
monthly to discuss the overall function and scientific opportunities for the ADRC, review each Core's progress,
and resolve problems within or between Cores. The Resource Distribution Committee, composed of the ADRC
Director, Associate Director, Core Leaders, Administrator, and ad hoc reviewers, evaluates all requests for data,
access to participants for enrollment in externally funded studies, ante-mortem biospecimens, and postmortem
brain tissue, and advises the Center Director and Executive Committee concerning resource utilization priorities.
The Administrative Core places strong emphasis on wide utilization of the Wisconsin ADRC resources, but
ensures distribution to support only high-quality research while avoiding competing uses for limited
biospecimens. The Development Project Review Committee will perform competitive review of all the
development projects submitted to the ADRC, prioritizing those from junior investigators with cutting-edge
research and a strong likelihood of attracting external funding. Overall, the Administrative Core will continue to
exercise scientific leadership and ensure ongoing success and excellence of the Wisconsin ADRC in the
renewed cycle of funding